Examining linkage to care after nonfatal opioid overdoses: A mixed-methods study.

PROJECT SUMMARY/ABSTRACT
The goal of the proposed fellowship is to prepare Mr. Jirka Taylor for an independent research career utilizing
qualitative and quantitative approaches to inform the development of drug policy, with a particular focus on
challenges and opportunities located at the intersection of various policy systems. The proposed fellowship will
help Mr. Taylor achieve this long-term career goal by enabling opportunities for individualized training: (1) to
become proficient in quantitative analyses using medical claims data, (2) to build expertise in advanced
statistical techniques, with a particular focus on causal inference, and (3) to gain in-depth understanding of the
health policy environment related to substance use and illicit drugs and become skilled in using policy data for
research purposes. To achieve these goals, Mr. Taylor will engage in activities including mentored research,
structured training via Johns Hopkins University coursework and informal training via independent study
programs, and attendance and presentations at seminars and conferences. Throughout the training period, Mr.
Taylor will receive support from a wide array of resources at the Johns Hopkins Bloomberg School of Public
Health and from a strong mentorship team with complementary expertise in policy research, large data set
analysis, advanced statistical and causal inference methods, and issues related to drug policy and care for
people who use drugs.
The mentored research will consist of a mixed methods study focused on improving care for people
experiencing nonfatal opioid overdoses. Non-fatal overdoses attended by emergency provide a chance to
initiate the treatment cascade of care by facilitating patients’ linkage to treatment and other services to help
address their needs. However, in practice, there are multiple points at which patients may disengage before
receiving effective care or where the cascade of care is interrupted. The proposed research aims to address
existing research gaps by analyzing individual, structural, and policy-related factors determining service use at
key post-overdose points of care. It will use advanced causal inference methods to investigate the impact of
Medicaid expansion on rates of non-transport by EMS after nonfatal overdoses. It will also analyze national
Medicaid claims data to identify predictors of post-ED treatment service update, focusing on the characteristics
of hospital-based care. Lastly, it will use qualitative interviews to describe the implementation of crisis
stabilization centers as an alternative to emergency departments for post-overdose care. Taken together, the
proposed research will strengthen the understanding of gaps in effective post-overdose linkage to care and
identify potential policy and practice mechanisms to mitigate their impact. The proposed research is strongly
aligned with NIDA’s Priority Scientific Area #4 to study the implementation of evidence-based strategies in real-
world settings.

Public health relevance
PROJECT NARRATIVE While non-fatal opioid overdoses attended by first responders provide a chance to initiate the treatment cascade of care by facilitating patients’ linkage to treatment and other services to help address their needs, in practice there are multiple points at which patients may disengage before receiving effective care or where the cascade of care is interrupted. The proposed research will be the first to comprehensively analyze individual, structural, and policy-related factors determining service use at multiple key post-overdose points of care – after the initial EMS encounter (Aim 1), after discharge from the emergency department (Aim 2), and in the community as part of an alternative model of care offered by crisis stabilization centers (Aim 3). The proposed research will provide evidence that can directly feed into policy and practice development in the area of post- overdose linkage to care, a policy area of focus emphasized by both governmental and professional organizations.